Illuminating Dynamic Receptor Clustering in the Epidermal Growth Factor Receptor Signal Transduction Pathway Using Plasmon Coupling

SUMMARY
The epidermal growth factor receptor (EGFR) is a model tyrosine kinase whose overexpression is common in
various cancers, including basal-like breast cancer (BLBC). It is becoming increasingly clear that EGFR underlies
not only conventional biochemical regulation induced by ligand-receptor binding but also much less well
understood spatial and temporal regulation mechanisms. A heterogeneous distribution of the receptor at the
plasma membrane results in an enrichment of EGFR in membrane regions with lateral dimensions of tens to
hundreds of nanometers where receptor dimerization and oligomerization is favored due to a high local
concentration of receptors. These clusters are not static but undergo continuous structural fluctuations. The
relationship between this dynamic structure and the local signaling activation are insufficiently understood, partly
because of a lack of appropriate optical tools for mapping subdiffraction limit dynamics with high temporal
bandwidth and long observation time. Aim 1 of this application takes advantage of the unique photophysical
properties of plasmonic nanoparticles (NPs) that provide large and stable optical signals and also encode
information about deeply subdiffraction limit separations between NPs in their far-field spectrum to characterize
the lateral diffusion and structural dynamics of individual EGFR clusters with high temporal resolution and without
physical limitation in observation time. Previous implementations of plasmon coupling microscopy (PCM) utilized
the NP spectrum detected under darkfield illumination to identify EGFR clustering. Dark-field detection requires,
however, large (~40 nm) NP labels. In Aim 1, we will implement a new interferometric PCM (iPCM) for detecting
5 nm (to probe EGFR-EGFR contacts) and 10 nm (to probe EGFR oligomerization and clustering) gold NP labels.
iPCM will be augmented with a correlation analysis to quantify continuous fluctuations in plasmon coupling. This
technology will be applied to test the hypothesis that EGF binding results in a decrease of intracluster dynamics
and an increase in EGFR phosphorylation. Another insufficiently understood element of structural regulation that
is associated with EGFR clustering is lateral signal propagation through inter-receptor contacts or EGF-induced
second messenger release. Aim 2 will elucidate how EGFR clustering impacts NP-EGF-induced reactive oxygen
species (ROS) formation and ROS-mediated EGFR activation. In this approach EGF-functionalized NPs (NP-
EGF) with known EGF loading are not simple imaging tools for mapping sub-diffraction limit clusters of EGFR,
but instead, represent quantifiably units of local EGFR activation. In Aim 3 nanoconjugated EGF will be applied
as probe to quantify the cross-talk between EGFR activation and nitric oxide (NO) formation. As NO synthesis
is spatially and temporally strictly regulated, its concentration depends on EGFR activation, which varies as
function of the local NP-EGF concentration. Aim 3 will test the hypothesis that NP-EGF-induced NO generation
is a regulatory factor for c-Jun N-terminal kinase (JNK)-mediated apoptosis in BLBC cells.

Public health relevance
Relevance to Public Health Dysregulation of epidermal growth factor receptor (EGFR) is indicated in a range of cancers, including basal-like breast cancer (BLBC). The project “Illuminating Dynamic Receptor Clustering in the Epidermal Growth Factor Receptor Signal Transduction Pathway Using Plasmon Coupling” develops nanoparticle-based tools to resolve dynamic spatial receptor clustering and to control the spatial regulation of EGFR activity. Nanoparticle-based strategies that facilitate the regulation of EGFR signaling provide new opportunities for therapeutic intervention in EGFR overexpressing cancers and can improve patient outcomes.